IAFF HazMat Training at DOE Nuclear Weapons Complex

The International Association of Fire Fighters (IAFF) proposes to continue its worker health and safety training
program to train workers, across multiple disciplines, within a 150-mile radius of DOE weapons complex
facilities in order to prevent work-related harm and improve worker-related health and safety. Through this
grant funding, the IAFF will deliver specialty courses including Hazardous Materials Technician, Confined
Space Rescue and Responding to the Interface (covers management of wildland fires that have, and continue
to, impinge on various DOE sites), as well as additional refresher training and Train-the-Trainer modules to
ensure program sustainment. The IAFF training has a successful history of development, update, and delivery
of such technical training programs, evidenced by high student pass rates, highly-rated survey responses, and
repeated positive third-party program reviews. The proposed IAFF training will be accessible to all
populations that may be responsible for preventing, responding to, or assisting in recovery of a HazMat
emergency including, but not limited to, fire and EMS personnel, law enforcement members, emergency
management and public health officials, industrial responders, as well as local community partners.
Through this continued cooperative agreement, the IAFF will:
1. Utilize advanced GIS and collaborative contact databases to identify and coordinate outreach to target
populations, giving consideration to increasing diversity and training of underserved populations.
2. Enhance the capabilities of workers on or around DOE sites through the delivery of updated and
improved curricula, that includes embedded training on important emerging topics, to improve overall
worker health and safety, and encourage increased worker and community resiliency.
3. Integrate new technologies (such as electronic tablets, an IAFF online library of tools and resources,
mobile hotspots, online apps, etc.) for course delivery, ensuring consistent deployment to all students
while also improving access to technology across all student populations.
4. Employ multiple, robust quality assurance protocols to provide defined benchmarks and measure
training effectiveness. The IAFF is dedicated to ensuring the training program meets and exceeds the
NIEHS Minimum Training Criteria Document resulting in workers who safety-conscious, strong
decision makers, positive role models, and who may serve as worker-trainers in their field.

Public health relevance
The International Association of Fire Fighters (IAFF) has been a partner with the National Institute of Environmental Health Sciences (NIEHS) Worker Training Program (WTP) since 1995, delivering training to workers on or around the DOE nuclear weapons complex (over 12,451 students trained through delivery of over 586 of classes during that time) to prevent work related harm and improve worker health and safety. The built environment in and around DOE facilities has become more complex due to increased population growth and impingement into the wildland urban interface, and workers face a number of emerging issues including occupational cancer risks, stressors impacting behavioral health and wellness, and an emphasis on improving provider and community resiliency. The IAFF is committed to addressing these issues, by: continuing and improving the training and education of all potential responders (public, private, or volunteer) required to manage HazMat emergencies; utilizing innovative technologies for class delivery; and conducting ongoing quality control and program evaluation.